Evaluating the role of immunomodulation in synergizing BMP-induced bone repair

Project Summary
The use of bone morphogenetic proteins (BMPs) shows promise as therapeutics for improving bone repair;
however, high supraphysiological concentrations required for the desired osteoinductive effect, costs, and
patient variability have prevented the full advantages of BMP-based therapeutics from being realized. Thus,
there is a clinical need to develop new bone tissue engineering approaches that promote osteogenesis at
lower BMP doses and prevent adverse side effects. Healthy bone formation and remodeling requires a delicate
balance between skeletal (e.g. osteoblasts) and immune (e.g. osteoclasts, macrophages, etc.) cells, which is
often overlooked when developing new bone regeneration therapeutics. To address these limitations, we
propose the use of immunomodulatory microparticles to enhance BMP-induced bone repair. Proteolytically-
degradable hyaluronic acid hydrogels will be used to co-deliver BMP2 and immunomodulatory microparticles
via cell-mediated hydrogel degradation. For the immunomodulatory microparticles, we have designed novel
poly(alpha-ketoglutarate) microparticles (paKG MPs), which sustainably release alpha-ketoglutarate (aKG)
upon hydrolytic degradation. aKG is known to regulate both osteoblast and osteoclast behavior. Furthermore,
paKG MPs are highly tunable, enabling precise control over aKG release kinetics. In this project, the ability of
paKG MPs to enhance BMP-induced osteogenesis will be investigated in vitro and in vivo. We hypothesize
sustained aKG delivery will enable control over the balance between osteoblast and osteoclast signaling,
leading to increased osteogenesis and bone formation. The proposed work will be accomplished through the
following aims: (1) Develop hyaluronic acid hydrogels with combined, sustained delivery of BMP2 and aKG;
and (2) Evaluate the effect of aKG on a) in vitro cell behavior and b) in vivo bone repair. A range of
microparticle concentrations will be tested to optimize aKG delivery. In vitro cell behavior will be evaluated via
viability, proliferation, metabolomics, differentiation (i.e. osteoblast and osteoclast markers), and mineral
formation and resorption. In vivo bone repair will be assessed using a critical-sized cranial defect rat model.

Public health relevance
Project Narrative The use of bone morphogenetic proteins (BMPs) shows promise towards therapies for improving bone regeneration in patients with trauma or disease; however, these approaches are limited by the high concentrations that are necessary for the desired therapeutic effect. Our innovative approach evaluates the ability of immunomodulatory microparticles to improve BMP-induced bone repair using both in vitro and in vivo models. If successful, this approach may lead to new treatments for patients that will decrease recovery times and costs.